Identifying the reservoirs of pathogenic bacteria in Illinois

Each year, foodborne pathogens cause hundreds of millions of illnesses and hundreds of thousands of
deaths globally. These numbers in the U. S. alone amounts to 48,000,000 and 3,000 per year,
respec�vely. The U. S. Food and Drug Administra�on (FDA) through its successful ini�a�ve,
GenomeTrakr, has taken considerable steps towards modernizing our food safety system by
implemen�ng and using whole-genome sequencing (WGS) in its inves�ga�ve and regulatory workﬂow.
Establishment of an interna�onal laboratory network and the crea�on of the GenomeTrakr database are
but two impressive accomplishments of this ini�a�ve. The GenomeTrakr laboratory network and its
database are the products of a scien�ﬁc vision that incorporates a global and data driven approach to
the problem of foodborne illnesses. However, despite signiﬁcant accomplishments of this ini�a�ve, a
cri�cal gap remains in our knowledge about the environmental reservoirs where pathogens like E. coli,
Salmonella, and Listeria reside and persist before contamina�ng the food supply. This in turn hampers
our preven�ve eﬀorts.
Our proposed project directly addresses this gap and supports the FDA's Laboratory Flexible Funding
Model (LFFM) Program by establishing and employing a dedicated capability for high-throughput
sequencing (HTS) of the microbial communi�es and WGS of foodborne pathogens isolated from the
posi�ve environmental samples (Track A5). The core scien�ﬁc work, detailed in the A5 Microbiology
Component, involves systema�c environmental surveillance across diverse agricultural and ecological
landscapes in Illinois. Our proposal is designed to meet this condi�on and will generate three main types
of data: a) the sequence data from microbial communi�es in the environmental samples; b) geographic,
topographic, meteorological and anthropogenic metadata; and c) WGS data from the pathogens isolated
from the posi�ve samples. To ensure consistency and replicability, we will adhere to current protocols
issued by the FDA's GenomeTrakr Program Coordinators in all our laboratory work and in data
dissemina�on and submission to the Na�onal Center for Biotechnology Informa�on (NCBI).
By characterizing pathogen reservoirs and contribu�ng genomic data from underrepresented
environmental sources, this project will improve our understanding of pathogen ecology, strengthen
na�onal surveillance infrastructure, and ul�mately support the development of more eﬀec�ve strategies
to prevent foodborne disease and protect public health. The project leverages the unique resources and
exper�se at the Ins�tute for Food Safety and Health (IFSH) at Illinois Ins�tute of Technology.

Public health relevance
According to CDC, foodborne illnesses are a major public health concern, causing 48 million illnesses and 3,000 deaths annually in the United States alone. By collec�ng and analyzing environmental samples— including water, sediment, soil, and soil components—this study aims to iden�fy and characterize major pathogen hotspots, explore the microbial communi�es they inhabit, and assess the role of environment and humans in their dynamic growth, spread and diversity. The data collected in this project will improve our understanding of pathogens, their ecology and evolu�on, and help us prevent and mi�gate disease outbreaks.